Partnering for Precision Medicine: A Collaborative Services Center for the All of Us Program

ROA Number OTA-23-002 | Partnering for Precision Medicine: A Collaborative Services Center for the All of Us Program3 ABSTRACT The All of Us Research Program (AoU) aims to expand program scientific capabilities to support a dynamic range of enrollment and research activities, including those involving pediatric populations, assessment methods, research services, scientific ancillary study protocols, and return of information to participants. Through the establishment of the AoU Participant and Partner Services Center (PPSC), the program will build on its prior successes to provide technology systems and direct and indirect research services to enable and facilitate participant enrollment and ongoing participation through standardized operational support in coordination with program partners. The key to the success of the PPSC is understanding the research process and building technological and methodological solutions that allow the AoU program to meet the needs of AoU participants and partners. As the PPSC partner, NORC will collaborate with NIH and other AoU partners to enroll new research participants while maintaining engagement from the participants already enrolled. Additionally, the PPSC will support the expansion of AoU to include new data collection methods and ancillary studies. Our proposal for the PPSC Research Technology Systems (RTS) Core combines our deep knowledge of multimodal data collection with technical expertise to design and configure the All of Us Participant Management System (APMS), based on a Salesforce and Qualtrics platform. These widely-used, secure, low-code/no-code platforms will allow for rapid implementation of the APMS and also facilitate future enhancements and additions to the AoU protocol. For the Program Management and Delivery (PMD) Core, we will provide indirect and direct research services supporting program and protocol operations for the AoU as it moves into the next phase and expands the scope to enroll children, conduct ancillary studies, and enhance coordination with program partners and participants. Full Participant and Partner Services Center Technical Proposal Use or disclosure of data contained on this page is subject to the restriction on the cover sheet of this proposal or quotation.